Task Order No. 71: "Training Institute for Dissemination and Implementation Research in Health 2017 (TIDIRH)"

Training Institute for Dissemination and Implementation Research in Health 2017 (TIDIRH)- Meeting support